Single cell opioid (fentanyl) responses in the context of HIV

Abstract
The number of drug overdose deaths has increased significantly in recent years. By 2019, 70.6% of drug
overdose deaths involved opioids, and in Ohio, >90% of unintentional overdose deaths involved fentanyl.
Opioid receptors are expressed in multiple peripheral blood mononuclear cell (PBMC) types that are
susceptible to HIV infection but poorly studied, particularly in those with HIV and fentanyl use.
We previously identified multiple differentially expressed genes related to apoptosis, antiviral/interferon
response, chemokine signaling, NFκB signaling, viral gene expression, and hepatocarcinogenesis that were
differentially regulated in the presence/absence of fentanyl in several cell types in vitro. In a separate NIDA-
funded R61/R33 focused on fentanyl and viral infections, we collected peripheral blood samples from >100
persons with HIV and/or HCV and active drug use, as well as healthy controls. Using a novel liquid
chromatography-tandem mass spectrometry-based approach, fentanyl was detected in 100% of patients
presenting with opioid overdose. Single cell transcriptome analysis identified multiple differentially expressed
genes in fentanyl-positive versus fentanyl-negative participants in CD4+ and CD8+ T lymphocytes,
monocytes, B lymphocytes, dendritic cells, and natural killer cells.
Translational research on opioid-cell and opioid-virus interactions is essential for optimized treatment and
limiting viral reactivation. Thus, we propose a multi-omics approach and complementary in vivo and ex vivo
studies in well-characterized patient cohorts to directly evaluate the impact of fentanyl on markers of the
single cell transcriptome and microRNA profile.

Public health relevance
Project Narrative The number of drug overdose deaths has increased significantly in recent years. By 2019, 70.6% of drug overdose deaths involved opioids, and in Ohio, >90% of unintentional overdose deaths involved fentanyl. Opioid receptors are expressed in multiple peripheral blood mononuclear cell (PBMC) types that are susceptible to HIV infection but poorly studied, particularly in those with HIV and fentanyl use. We previously detected fentanyl in 100% of patients presenting with opioid overdose. Single cell transcriptome analysis identified multiple differentially expressed genes in fentanyl-positive versus fentanyl-negative participants in CD4+ and CD8+ T lymphocytes, monocytes, B lymphocytes, dendritic cells, and natural killer cells. Translational research on opioid-cell and opioid-virus interactions is essential for optimized treatment and limiting viral reactivation. Thus, we propose a multi-omics approach and complementary in vivo and ex vivo studies in well-characterized patient cohorts to directly evaluate and validate the impact of fentanyl on markers of the single cell transcriptome and microRNA profile.